Role of Adiponectin in Reversal of Age-related Vascular Dysfunction

Aging is a primary risk factor for development of cardiovascular dysfunction and disease. The hallmarks
of vascular aging are endothelial dysfunction, development of a synthetic, atherosclerotic phenotype in
smooth muscle, and arterial inflammation and stiffening. We have shown that aerobic exercise training
can mitigate or reverse age-related vascular dysfunction and adverse arterial remodeling; however, the
cellular signals that contribute to the ability of exercise training to promote macro- and microvascular
resiliency remain unidentified. Similarly, the mechanisms whereby exercise training reverses age-
related vascular dysfunction remain unknown. Reduced circulating adiponectin has been associated with
the adverse vascular changes that occur with advancing age; however, a role for adiponectin in age-
related vascular dysfunction has not been demonstrated. We have reported that circulating adiponectin
levels increase in response to late-life exercise training; however, a direct role for adiponectin signaling
in reversal of age-related vascular dysfunction by exercise training has not been demonstrated. We
propose to test a central hypothesis that 1) loss of adiponectin is a critical contributor to age-
related vascular dysfunction and adverse arterial remodeling, and 2) adiponectin contributes to
the ability of exercise training to promote vascular resiliency and reverse age-related vascular
dysfunction and age-related adverse vascular remodeling. We propose to study sedentary and
exercise trained mice, across the murine lifespan, to determine 1) the impact of loss- and gain-of-function
of adiponectin on ceramide/sphingosine signaling in the endothelium of the microvasculature of the heart
and skeletal muscle, 2) the impact of loss- and gain-of-function of adiponectin on development of a
senescence-associated synthetic phenotype in vascular smooth muscle and contractile dysfunction the
microvasculature of the heart and skeletal muscle, and 3) the impact of loss- and gain-of-function of
adiponectin on remodeling of large arteries. Results from the proposed work will increase our
understanding of the role of adiponectin in age-related vascular dysfunction and exercise training-induced
reversal of age-related vascular dysfunction. A top biomedical research priority is to identify strategies
which promote vascular resiliency with advancing age or which reverse age-related vascular dysfunction.
The proposed work could identify 1) components of the adiponectin signaling pathway that could be
targeted for prevention of age-related vascular dysfunction, and 2) novel exercise mimetics that could be
employed for 1) promotion of vascular resiliency across the lifespan, and/or 2) reversal of age-related
vascular dysfunction.

Public health relevance
Adiponectin is a protein that circulates in high levels in the blood and which has known protective effects on the cardiovascular system. Aging impairs vascular function, but late-life exercise can reverse much of the vascular dysfunction related to advancing age. The overall goal of this application is to determine whether adiponectin plays a role in 1) the vascular dysfunction that occurs with advancing age, and 2) the ability of exercise training to promote vascular resiliency and reverse age-related vascular dysfunction.